Exercise as an Immune Adjuvant for Gamma Delta T-cell Therapies in Hematologic Malignancies

SUMMARY: Exercise as an Immune Adjuvant for gd T-cell Therapies in Hematologic Malignancies
gd T-cells are being considered as an alternative to standard CAR ab T-cells for treating leukemic relapse after
hematopoietic stem cell transplantation (HSCT), largely due to their ability to function across MHC barriers
without causing graft-versus-host disease (GvHD)1. gd T-cells can be readily expanded in vitro and in vivo using
zoledronate (ZOL) and have demonstrated anti-tumor activity in preclinical and early phase clinical trials, but
their efficacy against CD19-expressing tumors including acute lymphoblastic leukemia (ALL) and non-Hodgkin’s
lymphoma (NHL) has been modest3. Recently, CD19 CAR gd T-cells were found to have profound effects against
CD19+ tumors in vitro and in xenogeneic mice, albeit inferior to CD19 CAR ab T-cells, although CD19 CAR gd
T-cells were more effective at eliminating CD19 negative escape variants5, 6. As such, if the natural cytotoxicity
of gd T-cells could be enhanced they would become a highly attractive “off the shelf” therapeutic option for ALL
and NHL. Our goal is to improve gd T-cell therapeutics by collecting “superior” gd T-cells that have been mobilized
to peripheral blood by exercise or a synthetic b2-adrenergic receptor (AR) agonist and arming them with a CAR.
We will build on several novel and important observations we have made: (i) a single exercise bout
instantaneously mobilizes gd T-cells bearing a cytotoxic, co-stimulatory and tissue migration phenotype, allowing
their ex vivo manufacture with ZOL+IL-2 to increase by 100-300%4; (ii) exercise expanded gd T-cells have higher
in vitro cytotoxicity against several hematologic tumors4 and are more capable of inhibiting K562 leukemic growth
in xenogeneic mice, particularly when combined with ZOL sensitization; (iii) exercise skews expanded gd T-cells
toward an activated phenotype with heightened NKG2D, TRAIL, DNAM-1 and lowered NKG2A expression, and
blocking these activating receptors, or their ligands on K562 cells, abrogates the exercise effects on gd T-cell
cytotoxicity; and (iv) the mobilization of these superior gd T-cells with exercise is driven by b2-AR activation4. We
hypothesize that exercise will also enhance the quality of CAR gd T-cells by mobilizing gd T-cells with sustained
activation of cytotoxicity, co-stimulation, oxidative phosphorylation, homing and proliferation related genes, and
that this mobilization will be precipitated by increased cAMP signaling. Our aims are: 1) Determine if a single
exercise bout can improve the quality of CAR gd T-cells expanded from healthy donors. 2) Explore the
transcriptomic basis for the enhanced expansion and cytotoxicity of exercise mobilized gd T-cells and expanded
products. 3) Identify the b2-AR signaling pathways responsible for mobilizing gd T-cells with enhanced expansion
and cytotoxicity potential. Our approach involves the use flow cytometry, xenogeneic mouse models, single cell
RNA sequencing, and comparisons with CD19 CAR ab T-cells in human trials involving exercise with b-blockers
and b-agonist infusion models. We expect these aims to identify underpinning mechanisms and pave the way
for a clinical trial whereby exercise/b-agonist mobilized gd T-cells can be collected from donors and cancer
patients to increase the potency of CAR T-cell therapies to treat refractory disease and relapse after HSCT.

Public health relevance
PROJECT NARRATIVE Immune cell therapy with chimeric antigen receptor (CAR) T cells has been shown to cure some patients with leukemia and lymphoma, but the broad application of this therapy has been limited due to the need to engineer T-cells collected from the patient who will receive the therapy. We propose to test the efficacy of an alternative type of T-cell that is mobilized to the blood with exercise and can be safely given to a wider range of patients, potentially serving as an “off the Shelf” CAR T-cell product. We expect to identify how these cells are mobilized with exercise and ascertain the biological pathways that make them better equipped to kill cancer cells so that they can be utilized in a future clinical trial to treat patients with leukemia and lymphoma.